Integrated Demographic and Health Survey Data for Population Health Research

Project Summary/Abstract
This proposal seeks continued funding to expand and enhance IPUMS DHS, which eliminates barriers to over-
time and cross-national analyses with the Demographic and Health Surveys (DHS), the world's longest running
survey series on health and fertility in low- and middle-income countries. With powerful data discovery tools,
thousands of harmonized variables, easy-to-access documentation, and social and environmental context
variables linked to individual records, IPUMS DHS dramatically reduces the cost and increases the range, rigor,
and reproducibility of research on population health. The temporal and geographic scope of the IPUMS DHS
database enables cutting-edge population health research on topics including fertility, contraception, neonatal
and under-five mortality, low birth weights, child stunting and wasting, diarrhea, nutrition, food safety, obesity,
risky sexual behavior, access to health care, women’s empowerment, intimate partner violence, water and
sanitation, and the impact of armed conflict on reproductive choices. The proposed innovations to and expansion
of the database in the next phase will exponentially increase the potential research topics enabled by IPUMS
DHS. The continuation project has five specific aims: Aim 1. Achieve global coverage. IPUMS DHS now
incorporates microdata from 170 DHS surveys from 41 African and Asian countries, but it does not yet cover
Latin America, the Caribbean, Central and East Asia, Eastern Europe, or Oceania. The next phase will add
survey series from new regions, while also adding the latest surveys from Africa and South Asia. Aim 2. Unlock
comparative research across IPUMS global health databases. IPUMS DHS will become even more powerful
in the next phase when the database is made interoperable with other global health data series, such as
UNICEF’s Multiple Indicator Cluster Surveys (MICS). When coupled with data from MICS, almost 90 percent of
DHS countries will have three or more samples to compare across time, and 98 percent will have data from the
21st century. Aim 3. Enable cutting-edge research on the impact of social and environmental context on
health. The third project phase will triple the number of social and environmental context variables in IPUMS
DHS. With these new data, researchers will conduct path-breaking research, such as global comparisons of the
impact of rising sea levels on the health of individuals in communities near coastlines. Aim 4. Expedite data
analysis by simplifying or eliminating researchers’ data management tasks. Proposed enhancements will
enable users to filter samples based on topical content, variable availability, and country characteristics. We will
also develop an Application Programming Interface (API), allowing users to automate the tasks of defining and
executing data extracts. Aim 5. Support and expand our user community. IPUMS DHS is committed to
democratizing access to population data. The project will continue to provide robust individualized user support,
webinars, and workshops at key conferences, while introducing online tutorials and code-sharing opportunities.

Public health relevance
Narrative IPUMS DHS opens the door to the richest source of health data on low- and middle-income countries, revealing new opportunities for over-time and cross-national comparative investigations of population health. Only with intuitive, online access to integrated data like IPUMS DHS can scientists and policymakers address the world’s most pressing population health issues, make progress toward international development goals, and shift the balance toward greater global health equity in the face of ongoing challenges.